Theophylline Prophylaxis during Hypothermia to Limit Neonatal Nephron Damage

PROJECT SUMMARY/ABSTRACT
Acute kidney injury (AKI) is commonly seen in infants diagnosed with hypoxic-ischemic encephalopathy (HIE)
and is associated with increased rates of morbidity and mortality. Currently, there are no approved therapies
that target the prevention of AKI. Several small trials in infants with HIE suggest that a single dose of
theophylline given soon after birth attenuates the development of AKI. However, these studies were not
performed in infants being treated with therapeutic hypothermia (the current standard of care for moderate to
severe HIE), and only reported short-term outcomes. Therefore, few clinicians use theophylline in the
management of these patients. Our long-term goal is to undertake an appropriately powered multicenter
clinical trial to test the hypothesis that for infants > 35 weeks gestation treated with therapeutic hypothermia for
HIE, intravenous theophylline (or aminophylline) within the first 12 hours after birth will result in a decreased
incidence and/or severity of AKI or death (composite primary outcome) and improved long-term (2 year) renal
outcomes. Before the conduct of a large trial, the feasibility of implementing the intervention and ability to
measure relevant clinical outcomes need to be demonstrated. Therefore, we propose a small pilot and
feasibility clinical trial to i) evaluate recruitment, protocol adherence, and data collection procedures in a
therapeutic trial of theophylline to decrease the incidence of AKI or death compared to placebo in infants with
HIE being treated with therapeutic hypothermia; ii) evaluate the utility and applicability of established measures
(serum creatinine, urine output, fluid balance) and novel, exploratory approaches (urine biomarkers, large renal
tubular extracellular vesicles and renal oxygen saturation) to identify AKI in infants; and iii) determine
theophylline pharmacokinetic, pharmacodynamic, safety and preliminary effectiveness profiles of two different
theophylline dosing regimens in a therapeutic trial of theophylline to decrease the incidence of AKI or death
compared to placebo. Using a mixed methods data analysis strategy to assess the research and intervention
process and examine outcomes of the intervention, we will generate the requisite data to inform development
and implementation of an appropriately powered study to determine whether theophylline attenuates the risk
and severity of AKI in infants with HIE treated with therapeutic hypothermia.

Public health relevance
PROJECT NARRATIVE Acute kidney injury is a significant complication for infants who experience hypoxic ischemic encephalopathy, being associated with increased rates of death and prolonged hospitalization. Our pilot study of theophylline administration soon after birth for the prevention of kidney injury will lay the foundation for the conduct of a larger clinical trial that seeks to identify a theophylline as a novel therapy to prevent kidney injury in thousands of at-risk infants.